Regulation of T helper cell functions by aryl hydrocarbon receptor

Project Summary/Abstract:
Autoimmune diseases collectively affect over 23 million Americans and impose a huge burden of disease.
Many autoimmune diseases are characterized by pathologic T cell-B cell interactions and production of
autoantibodies. The T cell populations that help B cells in autoimmune diseases vary in phenotype and include
T follicular helper (Tfh) cells, which reside in follicles of secondary lymphoid organs, as well as T peripheral
helper (Tph) cells, which are B cell-helper T cells that migrate to inflamed peripheral tissues such as the
rheumatoid joint. Tph cells and Tfh cells share the ability to recruit B cells via production of a B cell
chemoattractant CXCL13 and then promote B cell differentiation through both surface interactions and
secreted cytokines. The signals that regulate development and function of Tph cells and Tfh cells in
autoimmunity remain incompletely described, and particularly little is known about T cell production of
CXCL13. Our preliminary data reveal the aryl hydrocarbon receptor (AHR), a ligand-gated transcription factor,
as a potent negative regulator of Tph and Tfh cell phenotype, with a dramatic effect on suppressing T cell
CXCL13 production. In this project, we utilize human primary T cells and patient samples to evaluate the broad
effects of AHR on Tph and Tfh cell development, function, and transcriptomic and epigenetic regulation. We
will evaluate the direct targets of AHR in human T cells via ChIP-seq and seek to identify new transcriptional
mediators downstream of AHR using CRISPR arrays. In addition, we will study synovial fluid and serum
samples from patients with rheumatoid arthritis and comparator conditions to evaluate alterations in the extent
of AHR agonist and antagonist activity in rheumatoid arthritis, a disease characterized by abundant
accumulation of Tph cells in the target tissue. We expect that this project will reveal novel mechanisms
mediated by AHR that regulate production of CXCL13 and key features of Tfh and Tph cell phenotypes.
Understanding the molecular control of these key T cell functions may highlight new strategies to interfere with
Tph and Tfh cells therapeutically.

Public health relevance
Project Narrative: T cells help stimulate B cells to produce autoantibodies in many autoimmune diseases, yet the signals that regulate whether and how T cells can stimulate B cell responses remain unclear. In this project, we study the role that a specific transcription factor, the aryl hydrocarbon receptor, plays in regulating the generation of B cell-helper T cells. This work may help understand how the aryl hydrocarbon receptor can be modulated to dampen autoimmue T cell-B cell interactions.